Knowledge Warding Against Toxin Levels, Community Engagement Core

PROJECT SUMMARY – COMMUNITY ENGAGEMENT CORE
The Community Engagement Core is run by the Kodiak Area Native Association (KANA), a 501 c (3) nonprofit
corporation and Tribal Organization and supports Center activities via community and tribal participation and
assessment, K-12 programming, and workforce development. These education, outreach, and
evaluative activities ensure that our Center's work, driven by Alaska Native Tribes, has meaningful and lasting
impacts. To achieve our first aim, evaluating impact, we create a Community Voices Panel to assess program
effectiveness, integrate local knowledge, and develop useful education materials, fact sheets, infographics,
and other culturally appropriate outreach to share data and findings. For our second aim, K-12 programming,
we create uniform educational materials to be used in classrooms across the Gulf of Alaska, particularly in
smaller and more remote communities, that increase education and understanding of HAB's, PSTs, and toxin
risks and promote safe harvesting practices. For our third aim, workforce development, we support interest and
career pathways to marine sciences by offering training and experiential learning experiences for college
students and developing online schooling modules.